Overcoming resistance to anti-PD1 immunotherapy

ABSTRACT
Novel immunotherapies for cancer are having a major clinical impact, in particular anti-PD-1
mAbs. However, the mechanisms that explain why a subset of patients responds to these
therapies while other patients do not remain incompletely understood. Our preliminary data
suggest that a baseline T cell-inflamed tumor microenvironment may be a predictive biomarker
for response to multiple immunotherapies. Combination immunotherapies may push clinical
efficacy in this subset of patients further. Our over-arching hypothesis is that germline
polymorphisms in the host, genomic features of the tumor cells, and the composition of
intestinal microbiota profoundly influence the extent of a spontaneous T cell response
against a patient's tumor, which in turn will determine the likelihood of response to
immunotherapy. Identifying molecular mechanisms for T cell exclusion should point towards
new therapeutic interventions that will expand the fraction of patients responding to anti-PD-1-
based immunotherapies. While our work to date has focused on melanoma, recent TCGA
analysis has indicated that many of the same principles apply to multiple additional cancer
types. Thus, a major goal of the proposed funding period will be to broaden our translational
research strategy to encompass patients with all cancer types being treated with anti-PD-1-
based immunotherapies. The output of this work is therefore anticipated to have profound
impact on cancer patient outcomes overall.

Public health relevance
PROJECT NARRATIVE The overall purpose of this proposal is to identify new strategies for cancer immunotherapy based on understanding the molecular features of the T cell-inflamed and non-T cell-inflamed tumor microenvironment. Our overall approach relies on a reverse-translational strategy of analyzing multiple dimensions of genomic data with respect to clinical outcome with anti-PD-1 treatment.